Conformational dynamics and allosteric regulation during stress-responsive metallocofactor assembly

PROJECT SUMMARY
Iron-sulfur (Fe-S) cofactor biogenesis is essential for most living organisms. The continuing long-term goal of
this renewal proposal is to characterize protein-protein interactions (PPIs) critical for bacterial Fe-S cluster
biogenesis by the Suf (sulfur formation) pathway, which is ubiquitous in prokaryotes including important
pathogens. Due to the toxic nature of free iron and sulfide in cells, Fe-S cluster assembly and trafficking is highly
choreographed by a complex network of protein partners. In Escherichia coli, Suf has evolved to act as an
emergency pathway that is activated under conditions of oxidative stress or iron starvation. In other bacteria,
such as Mycobacterium tuberculosis and Enterococcus faecalis, the Suf pathway is the sole source for Fe-S
clusters, making it an essential pathway and potential target for antibiotic development. The Suf pathway consists
of six proteins, SufABCDSE. SufS is a cysteine desulfurase that mobilizes persulfide (So) from L-cysteine.
Persulfide generated by SufS must be transferred to the transpersulfurase protein, SufE, prior to delivery to SufB
on the SufBC2D cluster scaffold. In vivo, Fe-S cluster assembly on the SufBC2D scaffold is dependent on the
ATPase activity of SufC and acquisition of iron, which is likely regulated by SufD. Following cluster assembly,
SufBC2D transfers the nascent cluster to SufA for downstream trafficking. While simple functional assignments
are available for proteins in the Suf pathway, lack of detailed mechanistic descriptions prevents the rational
design of small molecules to effectively disrupt the assembly process. During the previous funding period,
regulation of the sulfur mobilization step was characterized in detail. The overall goal of this proposal is to
investigate PPIs regulating cluster assembly and downstream trafficking. The hypothesis is that PPIs important
for regulating cluster assembly and trafficking are governed by changes in the structure/dynamics of Suf proteins
through the assembly process. We will test this hypothesis using a complementary, multi-pronged approach
including hydrogen/deuterium exchange mass spectrometry (HDX-MS), protein crystallography,
biophysical/biochemical characterization, and genetic complementation assays. To accomplish this broad
approach, a research team with diverse backgrounds and a productive track-record has been assembled. The
specific aims of this renewal proposal include: (1) characterization of Fe-S cluster-based regulation of
sequential protein-protein interactions with SufBC2D, (2) determination of the role of ATP in the function of
SufBC2D, and (3) identification of cluster trafficking interactions between the Suf system and the broader pool of
Fe-S cluster carrier proteins. Completion of the experiments described in the proposal will provide a rigorous
mechanistic description of how Fe-S cluster assembly and trafficking is regulated in the Suf pathway. These
results can be leveraged to design potential antibiotics targeting bacterial Fe-S cluster pathways and may inspire
novel therapeutic interventions for defects in analogous human pathways.

Public health relevance
PROJECT NARRATIVE Iron-sulfur clusters are essential for bacterial pathogens as these cofactors play many key biochemical roles. As the reactive iron and sulfide building blocks are toxic to cells, cluster biogenesis pathways rely on a complex network of protein-protein interactions to assemble and traffick the clusters. Studies in this proposal will provide much-needed mechanistic details on the role protein-protein interactions play in Fe-S cluster biogenesis and will enhance attempts to target this pathway for antibiotic development.